BioSpectroscopy Research Laboratory

The BioSpectroscopy Core Research Laboratory (BCRL) of the Center for Biomolecular Structure and
Dynamics (CBSD) at the University of Montana (UM) provides investigators with state-of-the-art imaging and
spectroscopy resources for investigating research questions in fields including, but not limited to, biochemistry,
biophysics, and neuroscience. The fluorescence technologies offered by the BCRL include both intensity-
based and time-resolved platforms, which provide high temporal and spatial resolution for visualizing and
measuring the dynamic structures and interactions of biological systems ranging in size from multicellular
complexes down to single molecules. Understanding, on the macroscopic scale, the spatial/dynamic
organization of interacting systems in cells and tissues, and on the microscopic scale, the dynamic structures
and the strengths and specificity of interactions of, for example biomacromolecules and their small-molecule
regulators, together afford critical insights into biophysical and biochemical mechanisms important in health
and disease. The BCRL resources are available either as fee-for-service or on a collaborative basis. The
BCRL also provides its technologies and expertise in fluorescence to research organizations and academic
institutions in the Pacific Northwest, including the University of Alaska (IDeA State) at Fairbanks and the
Canadian Center for Hydrodynamics at the University of Lethbridge, Alberta, Canada. The BCRL uses
reporting tools to track its effectiveness in providing services for clients, evaluating scientific outcomes, and
monitoring financial status. The BCRL also uses evaluation/survey tools to assess client satisfaction, ensure
effective operation, identify emerging needs, and prioritize new and ongoing projects. To ensure sustainability
beyond the Phase III COBRE, the BCRL will maintain a robust fee-for-service program, leverage institutional
support, and pursue grant-funded collaborations with UM investigators and external users.